Voltage-Gated Calcium Channels in Nociceptors and Mechanoreceptors

Project Summary/Abstract
No change from original submission.

Public health relevance
Project Narrative No change from original submission.